Using genetics and optogenetics to dissect how Rho signaling is coordinated at distinct subcellular domains to drive epithelial tissue morphogenesis

Project Summary/Abstract
During embryonic development, cellular cytoskeletal machinery produces mechanical forces to deform epithelial
tissue sheets into complex structures. Although the gene and protein regulatory networks that direct development
have been the focus of many studies, much less is known about how these patterned molecular programs
generate cell and tissue-scale forces to physically sculpt developing tissues and organs. Convergent extension
is a widely conserved morphogenetic process employed extensively across animal development, and its failure
is associated with common congenital anomalies in humans. However, the nature of the subcellular forces
directing tissue convergent extension remain poorly understood. Here, I propose using the Drosophila
melanogaster embryo as a model for dissecting the interplay of the actomyosin-generated subcellular forces that
direct cell intercalations during convergent extension. In Aim 1, I seek to quantify and correlate actomyosin
dynamics at cell apices, junctions, and lateral domains during both germband extension, in which contractility at
these domains cooperatively drives cell rearrangements, and ventral furrow formation, in which contractility at
these domains drives both in-plane cell rearrangements and out-of-plane tissue bending. Then, using genetic
mutants that disrupt actomyosin patterning in the early embryo, I plan to study how defects in coordination
between apical, junctional, and lateral actomyosin contribute to perturbed developmental phenotypes. In Aim 2,
I propose using optogenetic control of Rho signaling to specifically and simultaneously manipulate actomyosin
at cell junctions, apices, and lateral domains in order to build a bottom-up understanding of how actomyosin
coordination across different subcellular domains enacts distinct cell and tissue-scale morphogenetic processes.
I will use insight gained from endogenous germband extension and ventral furrow formation processes to
manipulate the frequency, duration, magnitude, and coordination of these distinct subcellular contractile
optogenetic inputs, and measure the resulting cell and tissue deformations. These studies will elucidate the
biochemical and mechanical nature of epithelial remodeling during convergent extension, contributing to our
understanding of healthy and perturbed developmental processes.

Public health relevance
Project Narrative Embryonic development involves extensive epithelial tissue remodeling and deformation, the failure of which results in congenital anomalies, including common neural tube defects. This research proposal seeks to use genetic and optogenetic approaches to dissect how subcellular patterns of molecularly generated forces work together to shape cells and tissues during development. By clarifying these conserved mechanisms of development, this study will build knowledge of the biomechanical behavior of developing embryos and help understand the molecular and cellular origin of neural tube defects and other congenital anomalies.